National Biomedical Resource for Electron-Spin Resonance Spectroscopy (ACERT)

Program Director/Principal Investigator (Freed, Jack, H.):
Specific Aims
The overall mission of ACERT (the National Biomedical Resource for Advanced Electron Spin
Resonance Spectroscopy) is twofold: (1) to take advantage of the latest developments in ESR
techniques to provide state-of-the-art facilities that enable molecular biologists to perform studies
that advance biomedical research, and (2) to provide advanced ESR-based services to scientists
working at the frontiers of molecular biology (taken in its most general sense), with long-term
benefits to the biomedical research community as a whole. A special opportunity for the ACERT
program is provided by upgrades to the ESR spectrometers, currently being completed.
ACERT will promote the application of cutting-edge instrumentation and techniques to some of
the most challenging questions confronting molecular biologists. We will use the expertise of ACERT
personnel, the administrative leadership team, and the external scientific advisory group to provide
support to molecular biologists using the facility.
Our primary aim in this supplementary request is to maximize spectrometer live time available for
the ACERT Resource users to enable accepting and processing more requests and to expand the range
of amenable systems by (1) implementing round the clock cryogen-free operation of the spectrometer
and (2) to further enhance its performance by installing commercial high-sensitivity sample
resonators.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page

Public health relevance
Project Narrative The ACERT National Biomedical Resource is a center to provide state-of-the-art facilities to researchers studying viruses, proteins, and other similar systems. The machines we use for this often involve cooling out samples down to liquid-helium temperatures. The costs of doing so are ever- increasing, so we are requesting funds to purchase a machine that will significantly reduce our helium use and let us make our machines available to more researchers.